THE MANIPULATION OF IMMUNE PROCESSES WITH HETEROCROSSLINKED ANTIBODIES

1. Human T cells and K cells targeted with anti-T3 and anti-FcR, heterocrosslinked to anti-tumor antibodies eradicate established human ovarian cancer cells in nude mice. 2. Heterocrosslinked antibodies containing an antibody against a soluble antigen linked to an antibody against a cell surface determinant on an antigen presenting cell (APC), greatly enhance the efficiency of antigen presentation. Enhance presentation has been seen when antigen was targeted to Fc receptors, surface immunoglobulin, MHC class I and MHC class II molecules on the APC. Targeted antigen presentation is antigen specific and I-A restricted.